MAGNESIUM REPLETION &CYCLOBENZAPRINE IN EOSINOPHILIA MYALGIA SYNDROME

To determine if low doses of tricyclic compounds, parenteral magnesium replacement, or the combination will lead to improvement in physical, psychiatric and neurocognitive function in chronic EMS patients.